Mobilize Center: Models for Mobile Sensing and Precision Rehabilitation

PROJECT SUMMARY
The Mobilize Center is a Biomedical Technology Resource Center (BTRC) with the goals of
creating and disseminating innovative tools to quantify movement biomechanics with mobile
technologies and deliver personalized mobile health rehabilitation programs. One of the
Center’s new tools is OpenCap, which enables researchers to quantify and analyze the
biomechanics of 3-D human movement from smartphone videos. This free, cloud-based tool
was released in July 2022. It is already in use by more than 1,500 biomechanics researchers
and has compiled data from more than 40,000 motion capture trials. As a BTRC, the Mobilize
Center also has training and dissemination aims, including an aim to create and maintain
data-sharing communities to accelerate research. Data-sharing is particularly impactful when it
comes to deep learning applications with their need for large datasets. OpenCap lowers the
barrier for communities to collect and process motion data, and therefore, presents an
opportunity to simultaneously advance the Mobilize Center’s data-sharing aim. However,
OpenCap’s primary purpose is data collection and not data sharing. It lacks key features for
open data sharing and scientific reproducibility, such as a mechanism to associate metadata,
search and filter datasets to download, link data to publication(s), register the data, and provide
a permanent reference (e.g., a DOI) to the data. Rather than reinventing the wheel for these
features, we will leverage SimTK, an online platform designed to promote open science. SimTK
is a web-based software, model, and data-sharing repository for the biocomputational
community with over 130,000 members. Specifically, we will make OpenCap interoperable with
SimTK by: 1) Integrating OpenCap and SimTK to support full-featured video and motion data
sharing, so that OpenCap datasets can take advantage of SimTK functionality to promote open
science, and 2) Extending SimTK’s API to enable OpenCap to collect standardized metadata.
Achieving these aims will expand the impact of our data-sharing aim, make OpenCap more
widely used, and increase the number, diversity, findability and re-usability of OpenCap’s
datasets.

Public health relevance
PROJECT NARRATIVE By making the smartphone-based OpenCap software interoperable with the SimTK repository, the large quantities of video and human movement data being collected through OpenCap will be shared broadly and in alignment with open-science community standards. In the biomechanics field, where median study sizes are 15, the new capabilities will increase the statistical power of existing datasets and enable the entire research community to investigate new questions that have been impossible to explore previously due to the large cohort sizes needed.